Tubulin microtentacles in detached mammary epithelial cells

Tubulin microtentacles in detached mammary epithelial cells.
Breast tumor cells metastasize to distant organs through non-adherent microenvironments, such as the
bloodstream or lymphatics. However, very little is known about the dynamic behavior and drug responses of
non-adherent tumor cells, due to the challenges of imaging non-adherent cells without blurring from cell drift.
The PI’s lab discovered unique microtentacles (McTNs) on the surface of non-adherent tumor cells that
promote the aggregation and retention of circulating tumor cells (CTCs) in the lung capillaries of living mice.
This project will test the hypothesis that actin cortical contraction regulates molecular mechanisms underlying
McTNs and can be targeted through independent pathways to reduce the clustering and reattachment of CTCs
during metastasis. Predictions of this hypothesis will be tested in the following specific aims.
Specific Aim 1: Inhibit kinases regulating actin cortical contraction to impact McTNs.
A) Define impact of pathway inhibitors on microtentacles and supporting molecular mechanisms.
B) Analyze inhibitor impacts on tumor cell mechanical properties (Brillouin microscopy, AFM).
C) Test prioritized drugs in zebrafish (CTC reattachment), mice (orthotopic, PDX) and live patient tumor cells.
Specific Aim 2: Test role of X-ROS mechanotransduction on McTN mechanisms and function.
A) Chemically inhibit TRPM8 and calcium signaling to influence McTN mechanisms.
B) Gauge effects of pathway inhibitors on MCAM and genetically regulating MCAM or TRPM8 (CRISPR).
C) Test prioritized mechanotransduction genes and drugs in zebrafish, mice and patient tumor cells.
Specific Aim 3: Target mechanisms of McTN-mediated tumor clustering.
A) Define McTN mechanisms that inhibit homotypic/heterotypic clustering with Digitoxin or Ouabain.
B) Downregulate desmosomal protein DSG3 to reduce McTN-mediated tumor cell clustering.
C) Test prioritized anti-clustering mechanisms in zebrafish, mice and live patient tumor cells.
This project will use innovative bioengineering techniques (TetherChip, Brillouin microscopy) and examine
highly-conserved mechanotransduction principles (X-ROS), recently identified by the PI’s lab in epithelial tumor
cells. Inclusion of FDA-approved therapies and drugs in current clinical trials will increase the potential to rapidly
translate the outcomes of this project to impact the clinical treatment of metastatic breast cancer.

Public health relevance
This project will test the role of actin cortical contraction in microtentacle formation and the clustering of circulating breast tumor cells. The PI’s lab has established the counterbalance between MT extension and actin cortical contraction and identified specific molecular mechanisms to alter this balance. Innovative bioengineering approaches, animal models, PDX and live patient CTCs will be used to test these mechanisms of targeting the actin cortex to reduce microtentacles.